GROWTH AND PITUITARY FUNCTION IN CANCER SURVIVING CHILDREN

This protocol evalutes the growth, physical development and pituitary function in children surviving oncology diseases. Possible alterations of physiologic mechanisms resulting in hormonal failure, including treatment modalities will be studied.